Neurophysiological and transcriptomic predictors of chronic low back pain: towards precision pain management (NEAT Study)

PROJECT SUMMARY
One of the most common and costly chronic pain conditions is low back pain (LBP), which produces more global
disability than any other condition. Up to 39% of patients with an acute LBP episode report chronic LBP (pain
lasting >3 months) and long-term disability for 2 years or longer. Increased mechanistic understanding of the
transition from acute to chronic LBP will enable us to identify biomarkers early in the transition period and new
therapeutic targets at critical windows of opportunity to prevent and/or better manage chronic LBP. In this study,
we will test the hypothesis that neurophysiological and gene expression differences can be used to build
a predictive model that will define the chronic LBP phenotype and transcriptome and identify those LBP
patients who will transition from acute to chronic pain phenotypes. We will prospectively follow a cohort of
380 LBP patients and 40 healthy controls (for comparison with LBP patients and to track gene expression stability
over time) for two years following the initial clinic visit for report of LBP. We will rigorously phenotype the
participants, including measurement of neurophysiological factors, and analyze gene expression at baseline and
regular intervals during the first year and at 18 and 24 months. We will accomplish these goals via two specific
aims: Aim 1: To examine neurophysiological predictors of the transition from acute to chronic pain at
baseline and over time following initial clinic visit for report of LBP. We will enroll participants at time of
initial LBP and follow them 6, 8, 10, 12, 16, 20, 24, and 52 weeks, as well as 18 and 24 months’ post onset. At
timepoints that correspond with blood draws for RNA-seq we will conduct neurophysiological testing to
characterize peripheral sensory nerve function, temporal summation (wind up) and conditioned pain modulation
(intactness of the descending inhibitory pain modulatory system). At other timepoints, participants will fill out
online questionnaires about pain and psychosocial constructs. Aim 2: To test the hypothesis that differential
expression of MHC locus genes at baseline and over time will be associated with the risk for chronic
pain, while differential expression of known pain genes will define the chronic LBP transcriptome. In this
aim, we will isolate total RNA from whole blood for sequencing at baseline and 6, 12, 24, 52 weeks, and 2 years.
We will examine how changes in gene expression differs in extreme phenotypes from three groups (n=20 healthy
participants, n=50 acute LBP, n=50 chronic LBP) at each of the six timepoints. In addition to biomarker
identification, we will conduct non-biased pathway analysis of the differentially expressed genes to gain
mechanistic insight into potential novel therapeutic targets for chronic pain prevention and/or management. This
study is highly aligned with NINR’s strategic plan and mission, the National Pain Strategy, IOM report, and the
NIH’s HEAL Initiative to identify biomarkers of the risk for chronic pain and therapeutic pain targets.

Public health relevance
PROJECT NARRATIVE Chronic low back pain (cLBP) is one of the most common and costly pain conditions in the United States, and a leading cause of disability. A majority of cLBP cases are not associated with underlying structural abnormalities, however, accumulating evidence suggests the prolonged, intense sensitivity to pain that characterizes cLBP is caused by distinct changes in expression of immune and other related pain sensitivity genes. The proposed study aims to discover gene expression biomarkers that predict cLBP so that we may uncover new therapeutic targets, identify patients at risk, and develop early, targeted interventions to reduce disability and improve quality of life for patients.